Evaluating the Safety and Efficacy of Targeting the Contact Pathway to Prevent Device Associated Thrombosis.

Project Summary
Our research project is designed to test our central hypothesis that the interaction between the
contact activation system of blood coagulation and the surfaces of medical devices contributes to
pathologic mechanisms including inflammatory responses and device associated thrombosis.
Despite the use of anticoagulation and antiplatelet agents, many widely used vascular devices induce
thrombus formation. Anticoagulation can mitigate thrombus formation, though not completely, and thus
thrombosis is a persistent risk with significant clinical consequences including thromboembolism, device
failure, stroke and even death. While current forms of anticoagulation can lessen these risks, they
universally increase the risk of bleeding, paradoxically contributing to patient morbidity and mortality.
Our group has extensively evaluated the contact pathway factors XI (FXI) and XII (FXII) which appear to
be complicit in the development of device-associated thrombosis, yet dispensable for hemostasis. Our
central hypothesis is that mechanical devices induce and propagate local blood coagulation and thrombus
propagation in a FXIIa-dependent manner. Building on our prior successes, in AIM 1 we will utilize in vitro
and non-human primate models, along with samples from patients with peripherally inserted central
catheters (PICCs) as a model medical device to define the interaction of the contact pathway and device
surfaces in the blood microenvironment. Using a novel inhibitor of FXII-mediated activation of FXI, in AIM
2 we will determine the role of contact activation in the development of device-associated thrombosis in
patients with peripherally inserted central catheters (PICCs). PICCs are frequently used in ambulatory
medical patients who require regular administration of intravenous medications, but are plagued by high
rates of thrombosis leading to local symptoms, thromboembolism and delays in medical care.
Paradoxically, the treatment of catheter associated thrombosis with modern forms of anticoagulation leads
to significant morbidity from major bleeding, and to date trials of traditional anticoagulants to prevent CAT
have not shown a favorable risk/benefit profile. There is an unmet medical need to develop safer more
effective therapies in this space.
Taken together, these analyses will be the first to define the mechanisms of by which activation of FXI and
FXII by device surfaces contributes to device-associated thrombosis in humans. The data generated from
this analysis will provide new mechanistic insights applicable to numerous medical devices used in
modern health care practices and has large translational relevance in identifying safe and druggable
targets within the contact activation system.

Public health relevance
Project Narrative Medical devices are common in healthcare, but often lead to morbidity in the form of device-associated thrombosis. Current strategies to prevent and treat device associated thrombosis are often ineffective and universally cause bleeding. There is an unmet need to develop safer and more effective therapies for device- associated thrombosis. Herein we will characterize novel druggable molecular interactions between the blood microenvironment and the surface of medical devices that contribute to inflammation and increased blood coagulation.